Restoring Northeast Cape for the Health and Well-Being of the Yupik Communities of St. Lawrence Island, Alaska

Our previous community-based participatory research at Northeast Cape (NEC) on St. Lawrence Island (SLI)
found elevated levels of polychlorinated biphenyls (PCBs), organochlorine pesticides (OCPs), and mercury
(Hg) in sediments and biota within the watershed at the formerly used defense (FUD) site. We found elevated
OCPs and PCBs in serum of the SLI people due to both long-range transport and military-derived sources, with
the highest levels of PCBs in people who have traditional and familial connections with NEC, including
subsistence. Concentrations of persistent organic pollutants (POPs) in our resident fish model, the stickleback,
closely mirror concentrations in the blood serum of SLI residents, indicating their efficacy as sentinel species
on SLI. Despite extensive remediation at NEC, short-lived lower trophic level fish in the Suqitughneq (Suqi)
River remain contaminated with PCBs, OCPs, and Hg originating from the FUD site, at levels that exceed EPA
fish consumption guidelines for cancer risk. Elevated contaminant levels and disrupted health in Suqi River fish
indicate potential health threats for residents and that site remediation is incomplete. Our overarching goal is to
advance scientific understanding of the exposure pathways and long-term human health consequences
associated with contaminant exposure from FUD sites and inform interventions necessary to protect the health
and long-term well-being of the people of SLI as they re-establish their traditional community at NEC. In Aim 1,
we propose to build on our prior discoveries and continue our collaboration with the communities of SLI to
investigate potential exposure pathways and biological impacts of persistent contamination associated with the
FUD site at NEC on SLI. We will analyze PCBs, OCPs, and Hg in the water of the Suqi and Tapisaggak rivers,
as well as in traditional foods and air samples to assess ingestion and inhalation as potential exposure
pathways. We will build on work with stickleback as a sentinel species to determine biological effects of
contaminants on endocrine function and organ-specific histopathology. In Aim 2, we will characterize and
quantify body burden of contaminants, and linkages to health outcomes, in people associated with NEC. In Aim
3, we will inform decisions and interventions to protect the health of the people of SLI and enable re-
establishment of the traditional community at NEC. We will provide information that will lead to improved
remediation, provide data and traditional knowledge to inform public health consultations and assessments,
and develop a community-based public health action plan and interventions to protect health, ensure equity in
decision-making, and restore the NEC community. This study will have local and circumpolar arctic
implications for Indigenous communities. Locally, we will provide data and implement actions necessary for re-
establishing the community at NEC. Given that thousands of such Cold War military sites exist throughout the
Arctic, often in close proximity to Indigenous communities, our project may serve as a model for environmental
and health monitoring and policy action by other Arctic Indigenous Peoples.

Public health relevance
Project Narrative The Yupik people of St. Lawrence Island are disproportionately affected by hazardous contaminants from formerly used defense sites that harm their lands, waters, traditional foods, health and well-being; they are also affected by the long-range transport of pollutants into the Arctic. This study addresses a primary environmental public health concern through investigation of the nature, extent, biological effects, and human health implications of contamination from the formerly used defense site at Northeast Cape on St. Lawrence Island, a major defense installation dating from the Cold War era that left a legacy of hazardous waste such as polychlorinated biphenyls (PCBs), pesticides, and mercury. The research will inform remediation decisions and public health assessments, and provide data and implement actions necessary for re-establishing the displaced traditional community at Northeast Cape, as well as serve as a model for improving health outcomes of arctic communities broadly.